Anastasis: A Novel Cell Survival Mechanism

Anastasis: A Novel Cell Survival Mechanism
Project Summary
Anastasis is a newly discovered cell recovery mechanism that rescues apoptotic cells from the brink of death.
Challenging the classic view of irreversible apoptosis, we have discovered robust reversibility of apoptosis in
three types of mouse/rat primary cells, twelve human cancer cell lines, and egg chambers in fruit flies. What are
the physiological functions, pathological roles, and therapeutic potentials of anastasis? Anastasis could
be an unexpected cytoprotective mechanism for preserving terminally differentiated cells and tissues that are
difficult to replace, such as cardiomyocytes and neurons. If true, enhancing anastasis may be beneficial for
treating heart failure and brain injury. Besides, anastasis could be an unrecognized escape tactic enabling cancer
cells to survive cancer therapy, thereby contributing to disease recurrence. If confirmed, suppressing anastasis
in dying cancer cells may promote cancer cell death and reduce the chances of recurrence. Anastasis may also
play important roles in limiting apoptosis during embryonic development and normal homeostasis. If identified,
understanding its regulation can provide new insights into the control of cell death and survival in physiological
conditions. However, there are several challenges of testing these hypotheses. It is difficult to track anastasis,
especially in vivo, because cells that have reversed apoptosis are morphologically indistinguishable from healthy
cells. There are no anastasis-specific hallmarks identified, and the regulators of anastasis remain undiscovered.
Here, we will overcome many of these challenges by developing a novel and highly specific tracking system to
label anastatic cells for mammalian studies, and to identify the key regulators of anastasis. To mark anastatic
cells, we will create an anastasis biosensor that can tag anastatic cells with permanent expression of a
fluorescent protein only after they have recovered from both mitochondrial outer membrane permeabilization
(MOMP) and caspase-3 activation, the two most recognized apoptotic events, making this biosensor system
highly specific to anastasis. We will establish anastasis biosensor stable cell lines to determine reversibility of
apoptosis in vitro, and will employ biosensor xenografts to interrogate anastasis in vivo using clinically relevant
mouse models. To elucidate the mechanism of anastasis, we will identify its key regulators, through proteomics,
genetics, and pharmacological approaches. We will identify which genes exhibit up- or down-expression
(potential anastasis regulators, and therapeutic targets) during different stages of anastasis, determine whether
specific post-translational modifications distinguish anastatic cells, establish whether cells that recover from
different cell death inductions share similar molecular features, and investigate how interfering with anastasis
regulator candidates could modulate the reversibility of apoptosis. We will identify small molecules that target
the candidates by bioinformatics, and test their efficacy in promoting or suppressing anastasis in vitro.
Successful completion of this project will generate essential tools and knowledge for studying anastasis, thereby
laying a strong foundation for developing revolutionary new therapeutic approaches by controlling anastasis.

Public health relevance
Project Narrative Anastasis is a newly discovered cell recovery phenomenon that enables dying cells to survive by reversing the apoptotic cell death process. The mechanisms and consequences of anastasis remain unclear. By developing a biosensor to detect anastasis in live animals, and identifying key regulators of anastasis, our project will develop critical tools and knowledge to study the physiological, pathological, and therapeutic implications of anastasis.